WU-SN-TMC Admin Core

Administrative Core Project Summary/Abstract
Administrative Core will provide executive oversight and administrative support for the construction of atlases
of cellular senescence for bone marrow, breast, colon, and liver tissue types by the Washington University
Cellular Senescence Tissue Mapping Center (WU-SN-TMC). We will also provide fiscal oversight and
infrastructure for communications across the three Cores, namely Biospecimen Core (BC), Biological Analysis
Core (BAC), and Data Analysis Core (DAC), and for scientific collaborations within the Cellular Senescence
Network (SenNet) and other companion NIH initiatives. The Administrative Core will administer a Pilot Project
program to draw on the best emerging scientific ideas and technologies to understand the biological
mechanisms governing senescence and advance the mission of the WU-SN-TMC and the entire SenNet. The
Administrative Core leadership team has a long history of participating in, and taking leadership roles within,
NIH-sponsored, multi-institutional networks; we will build on these experiences to work closely with the
Consortium Organization and Data Coordination Center (CODCC), technology development projects, and
other Tissue Mapping Centers (TMCs) to ensure the overall success of WU-SN-TMC and NIH SenNet
program.